Cross-links at abasic sites in duplex DNA

PROJECT SUMMARY
Endogenous DNA damage can contribute to aging, sporadic cancers, and neurodegeneration. There are
many sources of endogenous DNA damage, including oxidation, alkylation, nucleobase deamination, and
hydrolysis of the glycosidic bond to generate abasic sites. DNA repair systems mitigate the effects of these
endogenous damages, but some lesions inevitably evade repair with deleterious consequences. Importantly,
not all DNA damage is created equal. Interstrand cross-links are exceptionally bioactive lesions because they
block the DNA strand separation required for read-out and replication of genetic information in cells. Cells
have no good answer to cross-links in their genome: Failure to repair cross-links may lead to cell death,
tissue dysfunction, and aging, while error-prone repair may result in mutagenesis and cancer. The evolution
and retention of elaborate cross-link repair systems across all walks of life suggest that the generation of
endogenous interstrand cross-links is an unavoidable fact of life, but the identities of these cross-links and
their biological consequences remain uncertain. The long-term objective of this application is to assess the
occurrence and biological endpoints of endogenous DNA cross-links, which will contribute significantly to
overall understanding of cancer etiology. Work during the previous grant period characterized a group of
interstrand cross-links derived from an abasic (Ap) site that is the most common endogenous lesion found in
cellular DNA. The work further developed LC-MS methods for the detection and characterization of these
lesions in duplex DNA, and described a shuttle vector method for assessing the efficiency and fidelity with
which the Ap-derived cross-links are repaired and replicated in human cells. The proposed work, will (1)
conduct unbiased screens to comprehensively determine the sequence hotspots for Ap-derived cross-link
formation, (2) detect the occurrence of Ap-derived cross-links in cellular DNA, and (3) determine the
efficiency and fidelity with which Ap-derived cross-links are repaired in human cells and define the
mechanisms of replication-dependent cross-link “unhooking” in vitro and in human cells. The proposed work
explores the hypothesis that formation and replication-coupled repair of Ap-derived cross-links may be
particularly important in cancer, neurodegeneration, and aging. The work is significant because the
formation and repair of endogenous DNA cross-links may contribute to the causal processes involved in
aging and early carcinogenesis. The work is innovative because it examines structurally novel cross-links
and novel repair mechanisms, thus promising novel insights regarding the roles of endogenous DNA damage
in human health and disease. In the long run, the results may enable understanding of how genetic
differences in cross-link repair capacity contribute to human healthspan. Ultimately such insights could
inspire approaches that improve health by genetic means or by pharmacological agents that inhibit the
formation and/or enhance the repair of endogenous cross-links.

Public health relevance
PROJECT NARRATIVE A significant fraction of human cancers cannot be traced to known inherited genetic mutations or exposure to environmental carcinogens, instead they arise from endogenous (internal) damage to DNA that causes the introduction of mutations into the genetic code during DNA replication. Endogenous DNA cross-links could be an important source of mutations because the replication-coupled repair of these lesions is particularly error-prone due to the fact that, in cross-linked DNA, there exists no unmodified strand that can be used as a template to reconstitute the genetic code. Our work characterizing the formation and repair of interstrand cross-links derived from endogenous abasic sites in duplex DNA has the long-term potential to define how endogenous cross-links contribute to the causal processes involved in early carcinogenesis and how genetic variation leading to differences in endogenous cross-link formation and repair contribute to an individual's predisposition toward cancer and other aging-related illness.